In vitro modeling of a mammalian embryonic neural tube

Project Summary Creating in vitro models of mammalian neural development amenable to experimental manipulation and drug screening is critically important for delineating the molecular basis of, and developing clinical therapies for, neurological disorders that affect more than one billion people worldwide. Toward this goal, three-dimensional neural organoids have been developed and display some structural and functional features of neural tissues. However, while these organoids exhibit microanatomy similar to the authentic brain, they lack proper patterning along the Anterior-Posterior (AP) and Dorsal-Ventral (DV) axes and interactions with surrounding non-neural tissues that modulate their development and function. Thus, the neural organoids developed, to date, are unable to get input from sensory organs and disseminate signals to the rest of the body. Therefore, they cannot mimic a fully functional nervous system, strongly limiting their use. We seek to rectify this deficiency by building an in vitro embryo-mimetic system that contains a fully patterned neural tube, capable of receiving signals, and relaying them systemically. Our strategy is to initiate embryonic development in aggregates of mouse or human embryonic stem cells (ESCs), instructed with a spatially restricted morphogen activity center, which secretes WNT and NODAL and acts as an organizer. Our preliminary studies with murine ESCs show that these instructed aggregates develop into “embryoids” that gastrulate and form all three germ layers. Amongst them, 1/5 are patterned along AP and DV axes and are bilaterally symmetrical. These embryoids also contain a neural plate made of columnar neuroepithelial cells that progressively folds into a neural tube. While hindbrain and spinal cord are present, the embryoids lack the anterior most part of the brain, forebrain and midbrain. We hypothesize that the lack of anterior brain domains results from an excess of instructive signaling by the posteriorizing factors, and that correcting this problem will optimize this model for the study of normal and pathological neural development. In Aim 1, we will further define the cellular composition and spatio-temporal molecular anatomy of the developing nervous system of bilaterally symmetrical embryoids using high throughput single-cell transcriptome profiling, as well as tissue specific molecular markers. In Aim 2, we will promote formation of anterior brain domains by counteracting the potent gradient of posteriorizing factors WNT and NODAL secreted by the organizing center. Finally, in Aim 3, we will extend our study by producing and analyzing embryoids containing a neural plate that may fold into a neural tube, from human ESCs. For ethical reasons we will not attempt at producing the anterior brain domain to avoid the creation in vitro of a human organismal. Altogether, successful completion of these studies will establish robust in vitro models to study formation and function of the mammalian nervous system. It will also lay the groundwork for the creation of patient-specific human nervous system models, using human induced pluripotent stem cells.

Public health relevance
Project Narrative Efforts aimed at building in vitro models of the nervous system have led to the formation of organoids that display microanatomy similar to their counterpart in the authentic brain but lack proper organization of neural tissues and interaction with sensory organs and non-neural tissues. Our lab has developed an innovative and very promising approach to build embryoids that recapitulate proper embryonic development in vitro from aggregates of mouse embryonic stem cells. Our goal is to study in details the development of the neural plate and neural tube of these embryoids and to extend our study to the formation and analysis of embryoids built from human embryonic stem cells.